From genetic association to function: pleiotropic novel genes and variants linking lipid metabolism and cardiovascular diseases

PROJECT SUMMARY
Human genetic investigations have nominated hundreds of novel genomic loci harboring genes that influence a
range of cardiovascular (CV) diseases and their risk factors, including plasma lipids. However, only a fraction of
these novel loci have been investigated to determine the causal genes and underlying molecular mechanisms
leading to increased risk of—or protection from—CV disease. While LDL reduction is effective in reducing risk
of atherosclerotic cardiovascular disease, other common cardiovascular diseases such as peripheral arterial
disease, abdominal aortic aneurysm, and aortic stenosis have no effective non-surgical medical therapies.
Importantly, a growing body of human genetic data has identified that even beyond CAD, these additional CV
diseases have significant genetic associations with genomic loci/genes/variants that are also associated with
plasma lipid traits. This research program is focused on a systematic approach to fill some of the major gaps in
knowledge that link these human genomic loci to new biology, disease pathogenesis and potential therapeutic
targets. The goal is to provide a roadmap for how the hundreds of novel loci/genes/variants associated with CVD
might ultimately be investigated in an efficient manner. The focus will be on genes associated with both plasma
lipid traits and at least one major cardiovascular disease. Due to the liver’s primary role in lipid and lipoprotein
metabolism, the investigators will target liver-expressed genes. Furthermore, they will leverage naturally-
occurring protein-coding variation in genes that influence plasma lipids and CVD in order to gain greater insight
into the structure-function relationships of these proteins and relationship to phenotypes. This is an ambitious
program of research with two major Research Foci: Focus 1: Interrogation of novel putatively causal genes at
loci associated with both lipid traits and CV disease. Through systematic data ingestion and analyses of large-
scale GWAS and sequencing data, the study team will generate (and refine) a prioritized list of liver-expressed
genes at loci significantly associated with plasma lipids and at least one CV disease. Cell-based and murine
model systems will be used, accompanied by human studies, to validate causal genes and gain insight into the
physiological and molecular mechanisms by which they exert their influence. Focus 2: Leveraging protein-coding
variants to provide insight into structure-function properties of proteins influencing lipid traits and CV disease.
Through systematic analyses of large-scale public and private genomic data linked to phenotypes, the
investigators will develop a prioritized list of novel protein-coding variants associated with lipids and CVD and
perform comparative functional studies in model systems and in human carriers. The outcome of these studies
is expected to establish a firm biological basis for a substantial number of novel genes/proteins and protein-
coding variants that influence plasma lipoprotein metabolism and CV disease. The intent is to establish a
paradigm by which novel genes/variants associated with NHLBI-related phenotypes can be efficiently validated
and rapidly provided to the broader scientific community for further investigation.

Public health relevance
PROJECT NARRATIVE The proposed research program utilizes a systematic approach to investigate new genetic discoveries associated with blood lipids and cardiovascular disease (CVD). The investigators aim to demonstrate this through a paradigm of functional characterization of newly discovered lipid-regulating genes using naturally-occurring genetic variants. This effort will help bridge the significant gaps in knowledge linking human genomic discoveries to new biology and therapeutic targets and provide a roadmap for how novel genomic loci, genes, and variants associated with blood lipids and CVD might be investigated in a systematic manner.